2020 Drug Metabolism Gordon Research Conference and Seminar

Project Summary The 50th Drug Metabolism Gordon Research Conference (GRC) in 2020 will highlightunpublished, cutting-edge research patients as unique individuals, rather than populations, as a preparatory step to delivering precision therapeutics. that celebrates advances in the field over the past 50 years, with an emphasis on An essential component of the knowledge to be acquired is a clear understanding of the absorption, distribution, metabolism, and elimination (ADME) properties of the drug. The 2020 conference will include a keynote presentation on the integration of drug metabolism science and big data to inform precision medicine, and in celebration of the 50th anniversary the scientific sessions will provide cutting-edge contemporary updates on topics discussed at the first Drug Metabolism GRC, such as drug metabolism by the microbiome, mechanisms of drug metabolism and extrapolation of in vitro data to drug metabolism in vivo. Topics, such as membrane transporters, technologies like mass spectrometry and novel therapeutics entities, such as siRNA-based therapeutic agents unknown in 1971 will also be discussed. As expected for GRCs all presentations will include unpublished data, with sessions designed for maximal audience participation and discussion. Attendees are encouraged to submit posters for display at the poster sessions organized by the Vice Chair Dr. Jane Kenny. Posters are viewed during a 2-hour session every day of the conference which provides ample time for interaction. The Wednesday evening session will feature oral presentations by young investigators (graduate students, postdoctoral trainees and early career scientists) selected from the submitted poster abstracts. The conference is collegial and informal in nature, with ample opportunity to discuss unpublished research, make collaborative connections, and develop new ideas. Young investigators have easy access to mentoring from established investigators, as well as during informal career advice discussions planned during the week. There will be a session featuring an open discussion of challenges faced by women in science during the meeting led by two early career women scientists. Overall, the meeting will provide an opportunity for researchers in the ADME field to hear cutting edge science and have in depth discussions with colleagues that will facilitate collaboration, career development and learning.

Public health relevance
Project Narrative The 50th anniversary Gordon Research Conference (GRC) on Drug Metabolism in 2020 is entitled “Drug Discovery to Precision Therapeutics: Novel Mechanisms, Models and Technologies“. It will highlight that celebrates advances in the field over the past 50 years, with an unpublished, cutting-edge research emphasis on patients as unique individuals as a preparatory step to delivering precision therapeutics. The conference is designed to promote an atmosphere that facilitates cross-disciplinary scientific exchange, collaboration and mentorship.